ROLE OF HUMAN MILK IN INFANT NUTRITION AND HEALTH

The competitive renewal of our program project grant application is submitted by investigators who propose to continue their studies on the unique properties of human milk. All projects address the biologic consequence of specific milk components through protocols which utilize tissue culture, animal models and humans. the projects generally seek to define and characterize factors in human milk that protect newborn infants from disease. Certain consequences of the luminal milk- gastrointestinal tract interaction that pertain to protection of the infant will continue to be examined. Tissue culture or animal models will be utilized when study of human subjects is not possible, but human infants will be studied whenever appropriate. The respective projects and subcontracts will consider: 1) the role of soluble milk factors in the prevention of shigellosis; 2) the anti-inflammatory characteristics of human milk; 3) the role of the secretory immune system in rotavirus infection; 4) isolation, characterization and testing of the protective factor(s) in human milk against heat stable enterotoxin of E. coli; and 5) the role of human milk in the prevention of Campylobacter infection.